Pre- and Postnatal Exposure to Air Pollutants and the Gut Microbiome: Implications for Brain Development in Early and Mid-Childhood

ABSTRACT
Early life exposure to air pollution (AP), which disproportionately affects underserved communities, is thought to
disrupt cognitive, emotional, and behavioral development. Human studies show that exposure during the
prenatal and early postnatal periods are associated with developmental delays, autism, more severe attention-
deficit hyperactivity disorder, depression, and anxiety. Increasing evidence also suggests that exposure to AP is
associated with variation in the human gut microbiome, which other evidence suggests can alter brain physiology
and cognitive development. Despite these prior findings, no studies have considered the role of the gut
microbiome as a potential mediator of the effects of AP exposure on brain development and neurodevelopment
outcomes in early life. Further, human studies have focused on the associations of AP exposure with cognitive
outcomes at a single timepoint, and very few have examined AP-induced changes in brain structure and function.
Our overarching hypothesis is that AP exposure adversely impacts brain and neurodevelopmental outcomes,
and that these effects are partially explained by alterations in the gut microbiome. Our preliminary data show
that AP exposure is associated with a) poorer Bayley’s motor scores at 24-months, b) adverse gut bacterial and
fecal metabolic profiles at 6-months, and c) brain tissue microstructure and blood flow; and d) the newborn gut
microbiome is associated with brain measures. Our multidisciplinary team of investigators proposes to test our
hypothesis in a cohort of 200 Latino mother-infant pairs, with detailed assessments of maternal health and
nutrition, infant growth, and early feeding practices at 1, 6, 12, 18, and 24-months of age. Child cognitive,
language, and motor capacities were previously assessed using Bayley Scales at 24 months. With separate NIH
funding, we are currently collecting follow-up measures at 6yr, including anthropometric measures, nutritional
information, and current and cumulative environmental exposures to ambient and near-roadway AP. We will use
archived (1, 6, 12, 18, 24-months) and newly collected stool samples (6yr) to examine gut bacterial species and
fecal metabolic pathways (SCFA, lipid, amino acid, bile acid) that can alter brain development. Our specific
aims are to determine the extent to which early life exposure to AP is associated with neurodevelopmental
outcomes and brain measures (Aim 1), and with the gut microbiome and fecal metabolome (Aim 2) in early- and
mid-childhood. We further aim to determine whether air pollution-associated gut microbial profiles and fecal
metabolic pathways mediate the associations of AP exposure with neurodevelopmental outcomes and brain
measures (Aim 3). This study offers a unique opportunity to advance our understanding of the harmful effects of
early life exposure to AP. Results may also suggest interventions that could prevent or attenuate
neurodevelopmental disorders, such as limiting prenatal and early life AP exposure or other novel interventions
to promote or quell growth of specific gut bacteria.

Public health relevance
PROJECT NARRATIVE The proposed research will be the first longitudinal study to examine the effects of prenatal and postnatal exposure to air pollutants on the gut microbiome and fecal metabolome, and on subsequent brain measures and neurodevelopmental outcomes. Study findings will address a critical gap in our current understanding of the harmful effects of air pollution in early life, particularly alterations in gut bacterial species and fecal metabolic pathways that contribute to altered brain development and poorer neurodevelopmental outcomes.